Aberrant dopamine system function in a rodent model of perimenopause: relevance to psychosis

Project Summary/Abstract:
The transition to menopause (or perimenopause) is a period of unique vulnerability for a woman, in which there
is an increased risk of developing a psychotic disorder or the exacerbation of a pre-existing condition, such as
first onset schizophrenia/psychosis or bipolar disorder. Antipsychotics used to treat symptoms of psychosis, are
not always effective and are often discontinued due to adverse side effects. Further, when given to
perimenopausal women, antipsychotics can worsen common symptoms of this period (i.e., weight gain and
hyperprolactinemia). This is important to note because psychotic symptoms are debilitating and can severely
affect a woman’s quality of life. In the present proposal we will provide a mechanistic understanding into how
aberrant regulation of the mesolimbic dopamine system, by the ventral hippocampus, contributes to symptoms
of psychosis during perimenopause. We will address this using in vivo electrophysiology, chemogenetics, and
behavior with three specific aims: 1) Examine vHipp regulation of VTA dopamine neurons and dopamine-
dependent behaviors associated with psychosis in the VCD rodent model of perimenopause. 2) Evaluate the
impact of age on the psychosis-like effects of VCD. 3) Determine the utility of α5-GABAAR PAMs as a therapeutic
intervention for restoring dopamine system function and dopamine-dependent behaviors associated with
perimenopause in the VCD model. Our overarching hypothesis is that aberrant vHipp regulation of the
mesolimbic dopamine system during perimenopause underlies behavioral changes associated with psychosis.
Furthermore, we posit that α5-GABAAR modulators may have therapeutic utility during the menopausal
transition.

Public health relevance
Project Narrative: The transition to menopause is inevitable for aging women and is a stage in her life where she is vulnerable to developing a multitude of psychiatric conditions, including psychosis. The experiments detailed in this application aim to provide a mechanistic understanding into how aberrant regulation of dopamine neuron activity can lead to psychosis-like behavioral deficits in a rodent model used to study perimenopause. We will also investigate the utility of a novel GABAAR positive allosteric modulator that we believe may be used to treat symptoms of psychosis during perimenopause.